Vanderbilt Alzheimer's Disease Research Center: Neuropathology Core

PROJECT SUMMARY – NEUROPATHOLOGY CORE
The Vanderbilt Alzheimer’s Disease Research Center (VADRC) Neuropathology Core will lead the collection,
tracking, and distribution of postmortem brain samples to support the VADRC mission of characterizing how
vascular risk and disease intersect with Alzheimer’s disease (AD) and related dementias (ADRD) at the
cellular, systems biological, and population levels. The Neuropathology Core will build on the strong
neuropathological groundwork laid over the last few years and capitalize on previously established tissue
acquisition and processing pipelines to collect brain tissue and postmortem biofluids, assess neuropathologic
change, and develop a biorepository and digital slide library. The Neuropathology Core will work with the
Clinical and Outreach, Recruitment, and Engagement Cores to increase participant awareness about our brain
donation program and obtain consent using a Uniform Anatomical Gift Act. The Neuropathology Core will
perform tissue processing according to established guidelines, including immediate fixation and freezing. We
will perform ex vivo 3T and 7T imaging of all decedent brains to further characterize cerebrovascular changes
and for targeted sampling for histologic evaluation. In addition to capturing all standard neuropathologic
changes, we will also test for cerebrovascular disease, including arteriosclerosis, white matter pallor, enlarged
perivascular spaces, and white matter gliosis. These findings will be distilled into a comprehensive
neuropathology report for the decedent’s family. The Neuropathology Core will maintain a biorepository of all
characterized fresh and frozen tissue that is available for use by any qualified investigator. All biospecimens
will be tracked in conjunction with the Data Management and Statistical Core using Freezerworks and biofluids
will be sent to the National Centralized Repository for ADRD. A digital neuropathology slide library will be
generated and maintained, enabling broader distribution and sharing to further advance ADRD research.
Finally, in collaboration with the VADRC’s Research Education Component, the Neuropathology Core will
contribute to the professional development of interdisciplinary trainees through neuropathology-focused
didactics.